The Consortium for Technology & Innovation in Pediatrics: CTIP 3.0

Project Summary
The Consortium for Technology & Innovation in Pediatrics (CTIP 3.0) is a pediatric medical device consortium
based at Lurie Children’s Hospital (LCH) and Children’s Hospital Los Angeles (CHLA) established in 2011 and
funded by the FDA in 2013 and 2018. CTIP facilitates the development and commercialization of pediatric
medical devices by simultaneously engaging and coordinating clinicians, engineers, regulators, hospital
administrators, industry, patients, and the business community to guide and support medical device
development for children. For portfolio companies, CTIP fosters networking opportunities, clinical partnerships,
research and evidence generation, and direct and indirect financial support and expert guidance on issues
related, but not limited to, intellectual property, prototyping, engineering, testing, grant writing, business
development, regulatory strategy, and clinical trial design. CTIP has established a network of children’s
hospitals, academic institutions, accelerators, incubators, and ecosystem partners to support the
commercialization of pediatric medical devices. Over the past ten years, CTIP has expanded from southern
California, to the entire west coast, and now to a national consortium with academic and industry partners in
California, Oregon, Washington, Illinois, Colorado, Michigan, Missouri, and Wisconsin. CTIP’s overarching
goals are: 1) Accelerate pediatric MedTech forward, no matter how small or large the step, through non-dilutive
funding and comprehensive wrap-around services at every stage of the total product life cycle; 2) Connect
pediatric medical device innovators to our national network of experts and multidisciplinary stakeholders to
foster research, clinical, and business partnerships; and 3) Advocate for pediatric health equity and champion
pediatric-specific innovation through research, publications, public events, education, and collaborations. The
systematic barriers to pediatric device innovation are too complex for any one entity to address, so we have
worked tirelessly to be effective partners to the other PDCs, the FDA, healthcare organizations, investors, and
other ecosystem partners. By coordinating with larger organizations, we multiply our efforts and reach in the
field of pediatric medical devices. For the next funding cycle, CTIP plans to continue to deliver excellent
support to all of our portfolio members, and expand our activities in four key areas: 1) business development
and follow-on funding opportunities to ensure our companies have the financial runway they need to bring their
devices to market; 2) growing our robust pediatric medical device clinical trials infrastructure and services; 3)
engaging patients and families intentionally as partners in device development and advocacy; and 4)
addressing founders’ critical knowledge gaps in healthcare informatics, including data integration,
interoperability, cybersecurity, and EHR workflows. These new activities will help CTIP continue to build a
sustainable, needs-driven pipeline of new pediatric medical devices, with the ultimate goal of having more and
better devices available on the market that are designed to specifically meet the health needs of children.

Public health relevance
Project Narrative Very few devices are developed, tested, and approved specifically for children due to a number of financial, technical, and other barriers. The Consortium for Technology & Innovation in Pediatrics proposes to build on 10 years of success and continue accelerating pediatric device innovation through collaboration and support.